Core B

PROJECT SUMMARY
The Biostatistical Analysis and Mathematical Modeling Core will provide collaborative support to all
components of the Program Project in the form of study design, data analysis, and integrative modeling. The
Core investigators will function not only as technical consultants but as active intellectual partners in the
various aspects of transfusion medicine, inflammation biology, and cognitive science covered by the four
constituent studies. Both principals of the Core (Drs. Feldman and Mager) have lengthy experience in
biomedical research and expect to contribute on the highest level to the devising of study designs, framing of
hypotheses, formulation of analytic plans, interpretation of data, and dissemination of results from both human
and animal studies.

Public health relevance
RELEVANCE Effective statistical design and valid inference are keystones of clinical research, crucial to the clinical applicability and public-health value of biomedical investigations. The ready availability of high-level biostatistical and biomathematical collaborators, knowledgeable in the clinical field and expert in their technical discipline, is accordingly an essential element of a broad program of research such as proposed here. The four projects will be served and enhanced by the Core's statistical and modeling efforts, both in their pursuit of distinct scientific questions about neonatal anemia, thrombocytopenia, inflammation, sepsis, and neural sequelae, and in their collective implications when integrated into the larger clinical picture with potential benefit for neonatal practice.